Delaware Clinical and Translational Research ACCEL Program (CEO Core)

ABSTRACT – COMMUNITY ENGAGEMENT AND OUTREACH CORE
Engaging patients and communities in clinical and translational research improves the impact of research
because local communities are able to deftly identify the key questions and outcomes that matter most to
patients and communities. Such an approach requires strong partnerships across a spectrum of community
stakeholders, where there is clear recognition that the relationship between researcher and community
stakeholder must be reciprocal, mutually beneficial, cooperative and inclusive.
We use the term “community” broadly to include any and all “end users” of research. This includes patients,
families, neighborhoods, and other physically-defined communities within Delaware, but it also includes other
communities such as healthcare providers, health system leaders and administrators, public health agents,
condition-specific advocacy groups, payers, and policy makers--all of whom may benefit from our research.
Community engaged research (CEnR) is a collaborative process between the researcher and community
partners with the goal of developing knowledge & strengthening the well-being of communities.
The significance and impact of research depends not only on the quality of the research conducted, but also
on the degree and timeliness of translating findings into clinical, public health, and population health practices.
Developing approaches to incorporating the input and collaboration of end user communities early in the
research process through community engagement and outreach is perhaps the most impactful activity we can
do to significantly reduce the research to practice time gap and reduce health inequities.
The ACCEL CTR Community Engagement & Outreach (CEO) Core will make research more significant,
impactful, and responsive by enhancing and expanding the community engagement work of our earlier funding
cycles through the accomplishment of the following four specific aims: Aim 1: Assist Delawarean researchers
working across the translational spectrum (T0-T4) with identifying approaches to including community
perspectives in their work; Aim 2: Include community voice in all ACCEL CTR activities; Aim 3: Provide
expertise on health equity and disparities research, emphasizing the social and structural influences on health
(S/SIH); Aim 4: Develop a Practice & Community-Based Research Network (PCBRN)

Public health relevance
Project Narrative Please refer to the overall section.